Network Core

The KUH academic divisions (Kidney, Urology, Hematology) across Brigham & Women’s Hospital, Beth Israel
Deaconess Medical Center, Boston Children’s Hospital, and Massachusetts General Hospital along with the
Harvard Medical School Basic Science Departments oversee a robust pipeline of trainees and junior faculty with
research funding. HKUHTI faculty currently mentor more than 110 pre-doctoral and 442 post-doctoral students
funded by a range of mechanisms, including NIH T32 or F awards, individual foundation grants, or other
mechanisms. In just the last 7 years, over 40 trainees have successfully competed for NIH K awards. Building
off this successful ecosystem, the HKUHTI will enhance opportunities for future generations of highly skilled
young investigators to develop professional skills and pursue scientific discovery. This next-generation program
will offer exposure to varied scientific disciplines as well as innovative technical approaches and create both peer
and professional networks to support life-long pursuit of KUH research. In collaboration with other Cores and the
TL1, the Network Core will: Aim 1: Establish a Harvard-wide community of KUH trainees that is sustained
through regular scientific and social interaction among trainees and faculty. The HKUHTI will bring
together trainees supported by a range of NIH and other training mechanisms, mentors, academic and industry
leaders, and alumni through opportunities for professional and social interaction, including monthly scientific
meetings offering cross-disciplinary seminars and technology-based programs, as well as an annual scientific
retreat. Aim 2: Create a robust infrastructure and process for peer and near-peer mentoring, social and
professional networking, and career development. To promote a true community of trainees, the Network
Core will host quarterly, in-person, peer and near-peer mentoring, networking, and professional development
workshops, where trainees interact with each other and junior faculty K-awardees to discuss career development
strategies and promote joint problem solving. Aim 3: Expand existing outreach programs to strengthen and
diversify the KUH training pipeline. The HKUHTI will leverage existing institutional programs, including a
vibrant R25 program (Harvard Summer Research Program in Kidney Medicine) and Kidney Disease Screening
and Awareness Program that engage several hundred undergraduates across the country each year. Currently
focused on Kidney and, to a lesser extent, Urology, both programs will be expanded to integrate more
Hematology and Urology research and didactic opportunities, highlight successful role models and emerging
technologies, and incorporate HKUHTI trainees. In addition, the HKUHTI will collaborate with an existing Harvard
program to engage high school students in the Boston area for summer research in KUH laboratories together
with HKUHTI trainees. Together with the other Cores and the TL1, the Network Core will develop a community
to support and engage a diverse group of trainees, creating the next generation of KUH researchers and leaders.